The University of Chicago PREP

PROJECT SUMMARY
The University of Chicago Post-Baccalaureate Research Education Program (PREP) is designed to provide
research training and enrichment activities to recent college graduates from groups underrepresented in the
biomedical and behavioral sciences so they will be better prepared to apply, matriculate, and succeed in a PhD
program. It is based on the concept that an in-depth mentored research experience, along with enrichment
activities that help develop identity as a scientist, is the optimal preparation for graduate studies in the biomedical
sciences. The background and research interests of each participant are considered when selecting Mentors
who have outstanding records of promoting the training, education, and career advancement of biomedical
scientists for one year of full-time research. The research experience is complemented by a multi-tiered skill-
enhancement program for improving oral and written communication, critical thinking and analysis, and ethical
decision-making. Training in such skills is provided by a year-long PREP Journal Club, numerous workshops, a
writing course, an ethics course, academic courses, and other skill-building activities. Although the Program is
highly structured and logically organized, it is flexible in that an Individual Development Plan (IDP) serves as the
roadmap for each Scholar's course over their tenure in the University of Chicago PREP. The Program and its
components are assessed at specific intervals throughout the year, including both internal and external
evaluations. The ultimate success will be measured by the matriculation of Scholars into PhD programs, their
completion of PhD programs, and their long-term successes as biomedical scientists.

Public health relevance
PROJECT NARRATIVE The goal of the University of Chicago Post-Baccalaureate Research Education Program (PREP) is to help diversify the scientific workforce. The PREP provides mentored research experience in a biomedical laboratory and academic enhancements in the form of skill-building workshops and courses, in order to prepare postbac Scholars in the biomedical and behavioral sciences for admission to PhD programs at competitive research institutions. To assess the success of this endeavor, the Scholars’ progress will be followed throughout their graduate programs and subsequent career path.